Cellular mechanisms of peptidergic signaling

Project Summary
The secretion of growth factors, peptide hormones, neuropeptides and biogenic amines from neurons and
endocrine cells is a tightly-regulated event that drives physiological processes such as feeding, digestion, energy
storage, lactation, emotion and analgesia. Compromised peptide transmitter signaling is implicated in metabolic
and neurological disorders such as diabetes, eating disorders, depression, drug addiction, and Huntington’s
disease. Yet, the molecular pathways that govern the release of peptide transmitters, particularly in electrically
excitable cells of the nervous and endocrine systems, remain largely undefined. The objective of this proposal
is to uncover cellular mechanisms that regulate peptide transmitter secretion from mammalian central neurons.
Our central hypothesis is that peptide release from neurons is governed by diverse mechanisms in a cell type-
specific manner. We further posit that, similar to small synaptic vesicles, peptide release is tightly controlled by
neuromodulatory signaling through G protein-coupled receptors (GPCRs). Our innovative hypothesis challenges
the existing paradigm that focuses exclusively on intracellular calcium as the primary molecular determinant of
peptide release. The discovery of diverse release mechanisms will address long-standing questions surrounding
the challenges associated with evoking neuropeptide secretion. Our work will increase our understanding of the
neurophysiological events that drive and regulate peptide release in different neuron classes. The proposed
research builds on our recent establishment of several assays for monitoring the actions of neuropeptides in the
striatum and our successful development of diverse photoactivatable peptides for mimicking, and thus
calibrating, spatiotemporal aspects of endogenous release. Uncovering the general principles that govern
peptide secretion from neurons will establish new connections between intercellular and intracellular signaling
pathways and reveal how they are integrated at the molecular level in numerous biological systems that transmit
information via peptide signaling. In the long term, we anticipate that the new signaling pathways uncovered
might be exploited to treat metabolic diseases, psychological disorders and neurodegenerative disease, and
pain. By uncovering new connections between signaling pathways that are fundamental to human physiology in
both health and disease, the findings of this work will likely impact numerous scientific fields, including cancer,
cardiology, development, gastroenterology, and neuroscience.

Public health relevance
Project Narrative The release of peptide and hormone transmitters in the nervous and endocrine systems is compromised in diabetes, thyroid disorders, sleep disorders, eating disorders and depression. This work aims to elucidate cellular mechanisms that govern peptide secretion, which may lead to the identification of new drug targets for these and related diseases.